The Effect of Natural Killer Cell-Based Therapy on the HIV Reservoir

PROJECT SUMMARY/ABSTRACT
This grant proposal describes a five-year mentored training program for the career development of Dr. Jocelyn
Kim, a physician-scientist, who will develop cutting-edge methods to quantify the HIV reservoir and investigate
novel therapies to cure HIV infection. She has recently discovered that natural killer (NK) cells delays viral
rebound in a sophisticated humanized mouse model of HIV latency. She has also found that anti-HIV chimeric
antigen receptor (CAR)-on NK cells efficiently kill HIV-infected cells in vitro. In addition, a novel synthetic latency
reactivating agent (LRA) activates latent HIV in the presence of ART in vivo. Importantly, she has innovated a
genetically barcoded reporter HIV-1 and demonstrated that this diverse virus swarm is replication-competent
and pathogenic in vivo and forms a latent reservoir, which rebounds after cessation of antiretroviral therapy
(ART). She will use this novel barcoded-virus tool to accurately quantify the number of latently infected clones
in vivo. These preliminary data are the basis of the current proposal, which involves the completion of the
following aims. First, she will investigate whether NK cells from peripheral blood or hematopoietic stem cell
progenitors (HSCPs) are more effective in delaying HIV rebound in vivo using new methods of stem cell
differentiation and analysis. Second, she will test of efficacy of CAR-NK cells versus CAR-T cells on viral rebound
in vivo. Lastly, she will use state-of-the-art approach in genetic barcoded virus to determine whether
combinatorial therapies (LRA and NK cell-based therapies) affect the HIV reservoir in vivo. With K08 funding,
she we will complete these studies with the intention of deepening our understanding of HIV pathogenesis and
curative strategies. Dr. Kim is currently an assistant clinical professor in the UCLA Division of Infectious Diseases
and recent graduate of the UCLA Specialty Training and Advanced Research (STAR) program, from which she
received a PhD in Biology and Biological Engineering from California Institute of Technology under her PhD
advisor Dr. David Baltimore. During the proposed award period, she will continue under the primary mentorship
of Dr. Jerome Zack at UCLA with additional mentorship through an advisory committee comprised of Drs. Gay
Crooks (UCLA), Alex Hoffman (UCLA) and Judith Currier (UCLA). With their guidance, she will attain the
necessary research and career skills to apply successfully for independent funding and transition to
independence. As such, through her collaborations as well as didactic training, she will expand her NK cell
project and use complex computational skills for high-throughout barcode sequencing analysis to understand
the HIV reservoir. She will also acquire new skills in stem cell differentiation and analysis, molecular cloning,
and writing and grantsmanship. K08 funding will allow her to develop all of the skills and tools needed to become
a successful independent investigator.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Antiretroviral drugs can inhibit HIV infection, but cannot eliminate all the infected cells in the body that hide from the immune system. In order to cure HIV, we need to develop methods that accurately quantify the number of infected cells that remain hidden and explore new treatments that effectively target these HIV- infected cells. This project has scientific and public health relevance by deepening our understanding of how HIV remains hidden and ultimately uses this knowledge to develop curative strategies.